SOUTHEASTERN CANCER STUDY GROUP

The Southeastern Cancer Study Group is a multi-modality, interdisciplinary, multi-institutional group organized to conduct trials of therapeutic regimens for the treatment of cancer. Studies are concerned with all stages and sites except for central nervous system and pediatric tumors. Emphasis has shifted from palliative therapy of late stage hematologic malignancies to protocols with curative intent for early stage, poor risk solid tumors. In order to upgrade the quality and relevance of work, additional efforts are proposed in quality control for medical, surgical and radiation oncology, pathology review, steroid receptors and phase I studies.